Amino acid transporter SLC38A5 as a drug target for TNBC: Evaluation with genetic and pharmacologic approaches

Amino acid metabolism in tumor cells is very different from that in normal cells. The tumor-specific metabolic
pathway “glutaminolysis” focuses on glutamine. Recently, another fundamental pathway was discovered for
cancer cell proliferation: the “serine-glycine-methionine-one-carbon” pathway. Tumor cells upregulate
specific amino acid transporters to satisfy their increased need for glutamine, glycine, serine, and methionine
to fuel these pathways. Blocking the entry of these amino acids into tumor cells has potential for cancer
therapy. Recently, we provided evidence for this approach by identifying SLC6A14, an amino acid transporter
with broad specificity, that is induced in ER-positive (ER+) breast cancer (BC) and by showing that blockade
of this transporter reduces ER+ BC. But, SLC6A14 is not expressed in triple-negative breast cancer (TNBC).
TNBC must rely upon a different transporter as a “fix” to its “addiction” to glutamine/serine/glycine/methionine.
We have now identified this transporter as SLC38A5, a Na+-coupled uptake system exclusively for these four
amino acids. SLC38A5 is upregulated in TNBC by WNT/DVL1. Furthermore, SLC38A5 promotes
macropinocytosis, a unique feature essential for tumor growth. Here we will show that SLC38A5 drives the
glutamine- and one-carbon metabolic pathways in TNBC and evaluate in preclinical models the potential of
this transporter as a logical drug target for TNBC. We have identified the FDA-approved drug niclosamide as
a potent inhibitor of SLC38A5 function and expression. This drug can be used pharmacologically to interrogate
the role of SLC38A5 in TNBC. We also have Slc38a5-null mice as a genetic tool for these studies.
Hypothesis: SLC38A5 drives the glutamine-dependent and one-carbon metabolic pathways in TNBC; as
such, pharmacologic inhibition or genetic deletion of SLC38A5 will block TNBC. We will test this hypothesis
with two aims: (Aim 1) Demonstrate that SLC38A5 is obligatory for glutaminolysis and one-carbon metabolic
pathway to promote cell proliferation and remodeling of the epigenetic landscape in TNBC cells and elucidate
the molecular mechanisms by which WNT/DVL1 induces SLC38A5 in these cells. Here we will use classical
as well as patient-derived xenograft TNBC cell lines. (Aim 2) Evaluate the impact of SLC38A5 loss on tumor
growth in mouse models of TNBC using Slc38a5-/- mice and niclosamide as a proof-of-concept for future use
of this transporter as a selective drug target for TNBC. Here we will use xenografts of human TNBC cell lines
in nude mice to evaluate the anticancer efficacy of niclosamide, and also compare the development/growth
of spontaneous mammary tumors in a TNBC mouse model [C3(1)-TAg mouse] with and without niclosamide
treatment (pharmacologic) and on Slc38a5+/+ and Slc38a5-/- backgrounds (genetic). Impact: With no known
targeted therapy, chemotherapy is the only option for TNBC. Establishment of SLC38A5 as a drug target
would aid future use of pharmacologics (e.g., niclosamide) to block its expression and transport function as a
targeted therapy for TNBC, either as a monotherapy or in combination with standard chemotherapeutics.

Public health relevance
Tumor cells rely upon glutamine-dependent metabolic pathways as well as serine/glycine/methionine-driven one-carbon metabolic pathway for their proliferation and growth; the amino acid transporter SLC38A5 supplies these four amino acids to triple-negative breast cancer (TNBC) cells. As TNBC has no effective targeted therapy, our goal is to show using in vitro studies with cell lines and in vivo studies with appropriate preclinical mouse models that pharmacologic blockade of SLC38A5 is a logical approach for targeted treatment of TNBC.